Oxytocin receptor signaling modulates social attachment via hippocampal CA2/3 function

PROJECT SUMMARY. Social attachments play a central role in every level of human interaction, from
relationships between parents and children to enduring partnerships with mates. A major barrier to understanding
the neural basis of this behavior is that mice and other traditional model organisms do not exhibit complex
attachments. In contrast, prairie voles (Microtus ochrogaster) form social attachments and demonstrate enduring
social monogamy between mates. Such attachments result in a preference for bonded partners and the robust
rejection of novel conspecifics, both of which require social memory of specific individuals. This suggests that
key regions such as the hippocampus contribute to the affective and behavioral responses to a given individual.
Hippocampal areas CA2 and CA3, specifically, are implicated in social memory and the display of agonistic
behaviors towards novel intruders in mice. Importantly, hippocampal CA2/3 is modulated by oxytocin, a key
neuroendocrine mediator of attachment behaviors. However, how CA2/3 and oxytocin receptor (OxtR) signaling
therein contribute to pair bonding is unknown. This proposal will delineate the molecular, cellular, and functional
mechanisms by which neuroendocrine signaling in the hippocampus contributes to social attachment in the
socially monogamous prairie vole. In the mentored phase of this research plan, we will identify sex- and species-
specific spatial distributions of cell types and neuroendocrine receptors in the vole hippocampus. To do this, we
will conduct single-nucleus RNA sequencing of the hippocampus in combination with multiplexed error robust
fluorescence in situ hybridization (MERFISH). In the independent phase, we will test the hypothesis that CA2/3
and OxtR signaling therein mediate the rejection of novel, potential mates in the prairie vole. First, we will
determine the hippocampal neuroendocrine cell types activated by exposure to a partner vs. a novel stranger
using MERFISH with immediate early gene imaging in bonded prairie voles. Second, we will test CA2/3 ensemble
responses to social interactions with partners and strangers across pair bonding using miniscope imaging. Third,
we will test whether CA2/3 activity and CA2/3 OxtR function are necessary for pair bond maintenance by a)
chemogenetically inhibiting CA2/3 or b) locally delivering an OxtR antagonist prior to assays for stranger rejection
in pair bonded voles. These studies will provide novel insight into the neural mechanisms governing social
attachment and their modulation by oxytocin, ultimately contributing to the BRAIN Initiative priority areas of
identifying cell types, monitoring neural activity, and using interventional tools to understand the neural basis of
complex social cognition. This work will be conducted at the University of California, San Francisco, a premier
research institution with ample research and career development resources. I will receive training in
transcriptomics, bioinformatics, and professional development. For this, I have assembled a mentorship team
that will provide expertise for every aspect of my training and will help me to accomplish my goal of becoming
faculty at a top institution.

Public health relevance
PROJECT NARRATIVE. Social bonds with friends and loved ones are critical to our physical and mental health; however, we currently lack a basic understanding of the neural circuits that underly this fundamental human behavior. In this study, we use cutting-edge spatial transcriptomics and circuit manipulations to understand how the hippocampus, a region critical for social memory, contributes to social attachment in the monogamous prairie vole. We will test the role of the social neuropeptide oxytocin in this region and uncover new signaling mechanisms underlying hippocampal regulation of behavior, ultimately driving us towards mechanistic therapies for numerous psychiatric disorders that are accompanied by the deterioration of social interactions.